Human Endogenous Retroelements in HIV Immunopathogenesis

DESCRIPTION (provided by applicant): Human endogenous retrotransposable elements (HEREs) make up approximately 42% of the human genome. Included amongst these elements are the LTR associated human endogenous retrovirus insertions (HERVs), and the non-LTR associated long and short interspersed nuclear elements (LINE and SINE). The prevalence of HERV elements has resulted from the accumulation of past retroviral infectious agents that have entered the germline and established a truce with the host cell. LINE and SINE elements, which are not thought to have been derived from infectious precursors, have proliferated throughout the genome by a 'copy and paste' retrotransposition mechanism. Recent data have shown that these elements are under the cellular control of the innate resistance factors APOBEC3B, 3A, 3F and 3G. We have generated data that show HIV-1 infection of primary CD4+ T cells and macrophages in vitro resulted in enhanced levels of HERE transcripts, and the accumulation of additional HERE genomic copies, indicating the induction of successfully completed retrotransposition events. HERE proliferation was restricted to HIV-1 infected cells. HERE transcripts in the plasma were detected in individuals with acute/early HIV-1 infection not on antiretroviral drug treatment. These latter individuals had detectable ex vivo T cell responses to HERV antigens, and the magnitude of the anti- HERE response inversely correlated with HIV-1 plasma viral load. This grant proposes in 3 specific aims to understand the consequence of HERE antigen production and presentation in HIV-1 infection, and to determine whether the immune response generated to these elements can eliminate HIV-1 infected cells. In the 1st specific aim we will ascertain the breadth and degree of endogenous retroelement expression (LINE-1, HERV-K) in HIV-1 infection. In the 2nd specific aim we will determine the relationship between anti-HERE T cell response and HIV-1 plasma viral load. In the 3rd specific aim we will determine if anti-HERE T cell clones recognize virus infected cells in vitro and if they can suppress HIV-1 viral replication in a viral inhibition assay. Our preliminary data indicate that HIV-1 infection leads to HERE expression and stimulates a HERE-specific immune response, suggesting a novel vaccine strategy against HIV-1. Elicitation of T cells against HEREs by vaccination would lead to T cell recognition of HIV-1 via both cross-reactivity between HEREs and HIV-1 and independent recognition of HERE antigens produced by HIV-1 infected cells. The work proposed in this grant aims to better understand the role of HERE expression and immunity in the pathogenesis of HIV-1 infection and to generate data for a novel vaccine strategy against HIV-1.

Public health relevance
Project Narrative The goal of this proposal is to better understand the interaction of endogenous retroelements, the "fossil viruses and junk DNA" in our genome, and HIV infection. This information will be used to devise future studies to treat HIV infection and design a novel vaccine against HIV/AIDS.